Fine-resolution genetic mapping of advanced intercross lines of Biomphalaria glabrata

SUMMARY
The control and treatment of schistosomiasis currently rely solely on praziquantel, a drug that has been in use
for over 40 years. However, praziquantel is imperfect because it cannot kill juvenile schistosomes and does not
prevent reinfection. Additionally, there is no effective vaccine against schistosome parasites. Therefore,
alternative tools are urgently needed to fight schistosomiasis. One alternative strategy is the genetics-based
biocontrol of snails by disrupting the intramolluscan life cycle of schistosomes before the release of cercariae
(the infectious stage of schistosomes), thus preventing human infection. To support this strategy, we have
developed advanced intercross lines of Biomphalaria glabrata, an important snail vector of the human blood
fluke Schistosoma mansoni and a well-studied model for schistosomiasis research. These advanced intercross
lines have been developed through our long-term efforts to develop genetic and genomic resources in B.
glabrata aimed at understanding compatibility between snails and schistosomes. These AI snails possess four
different resistance phenotypes: extreme susceptibility, moderate susceptibility, moderate resistance, and
extreme resistance. These phenotypes enable us to explore the mechanisms that regulate the number of
cercariae shed by individual snails, referred to as per capita cercarial production. Per capita cercarial production
largely determines the total number of cercariae present in the water, thereby affecting schistosomiasis
transmission in endemic areas. In this project, we propose to use double digest restriction-site associated DNA
sequencing (ddRADseq) and pooled sample sequencing (Pool-seq) to genotype the AI snails. We will employ
genome-wide association studies (GWAS) and quantitative trait loci (QTL) analyses to investigate the genomic
regions and genes in those regions that control schistosome resistance, specifically per capita cercarial
production. Completing this study will enhance our understanding of snail resistance to schistosomes, thus
facilitating the development of innovative snail-targeted biocontrol programs for schistosomiasis, a parasitic
disease that affects 251 million people worldwide.

Public health relevance
Public Health Relevance Snail control has proven highly effective in controlling schistosomiasis, a parasitic disease that affects 251 million people globally. This study will utilize newly developed genetic resources to decipher the genetic mechanisms underlying snail resistance to schistosomes, which can aid in developing innovative biocontrol strategies for schistosomiasis.